MARKOV PROCESSES AND CLINICAL TRIAL DESIGN

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Early stage clinical trials for serious diseases like cancer pose serious challenges in balancing the risks and benefits for the patient enrolled with the costs and benefits to the community, especially the value of the scientific information to be gained. In principle, decision theory provides a clear rational solution to the problem. However, evaluating the value of future knowledge to be gained involves combinatorially explosive calculations. This work adapts and evaluates several approximation methods, including some fairly recent techniques developed for later-stage clinical trials, and also techniques from planning and robotics for solving partially observable Markov decision processes